The ITZA Program: Indigenous HIV/AIDS Research Training 3 (IHART3) Program

The Indigenous people of the Americas experience persistent and dire health disparities related to HIV/AIDS.
Despite the glaring disparities, there is a paucity of culturally grounded research addressing their biomedical
and socio-behavioral health concerns. A strong network of highly trained Indigenous scholars dedicated to
culturally relevant HIV prevention research would contribute to ameliorating HIV-related health disparities
among Indigenous people. This competitive renewal application, in response to PAR-17-485: NIMH Research
Education Mentoring Program for HIV/AIDS Researchers (R25), proposes a third iteration of the Indigenous
HIV/AIDS Research Training Program (IHART). IHART3-Itza will develop a cadre of culturally grounded Native
scholars capable of serving as PIs on extramurally funded HIV/AIDS-related prevention and disparities studies
with Indigenous populations. The IHART3-Itza program is based on the success of the first 10 years of IHART
(IHART and IHART2-Lauhoe), the only Native-specific HIV/AIDS research education mentorship program in the
US. IHART3-Itza extends the reach of the original IHART programs from American Indians/Alaska Natives,
Native Hawaian/Pacific Islanders, underrepresented racial/ethnic groups, and non-Natives working in Indian
Country to include as well the historically underserved Indigenous Latinx Populations (ILP). ILP include people
originally or descended from Indigenous communities in Mexico and Central and South America. Whereas
IHART2 focused primarily on newly postdoctoral scholars, IHART3-Itza will target more experienced early-
stage investigators (5-10 years post-Ph.D.) interested in developing novel expertise in HIV prevention
research. Finally, the program will target recruitment of scholars residing in or working in the US HIV hot
spot regions of the Southeast and West. IHART3-Itza will continue to employ a successful 360 degree co-
mentorship approach with flexibility for program Fellows and Mentors to co-identify HIV training, career
development, and cultural needs of the Fellow. To achieve the overall objectives of IHART3-Itza, we will select
15 Fellows (3 per year over 5 years) who will undergo a structured 24-month intensive year-round mentorship
program that includes: (a) an annual 2-day Summer Research Institute, 5-day writing retreat, and 3-day
Scientific Roundtable and grant writing workshop; (b) other training opportunities (webinars; 4 quarterly
seminars; on-site mentor shadowing opportunities; and support for participation in HIV/AIDS training institutes
and scientific conferences); (c) statistical, editorial, and technical assistance for developing grant applications
and writing manuscripts for publication); (d) seed funding ($22,000 for pilot studies); and (e) network
development (via mentor networks and website). By the end of the 24-month program, Fellows will have
written a pilot grant application, obtained human subjects approval, designed and implemented a funded pilot
study, published HIV/AIDS-related articles, submitted and presented HIV-related conference abstracts to
national conferences, and begun to develop an HIV-related NIH grant application.

Public health relevance
Project Narrative Consistent with the main objectives of NIMH R25s, this IHART3 program provides a 24-month HIV/AIDS research mentoring program to 15 primarily Indigenous scholars (postdoctoral/early-career stage) to facilitate their careers in HIV research among Indigenous communities.